New Evidence on the Role of Federal Funding in Reducing the Prevalence of Obesity

PROJECT SUMMARY
Over the last twenty years, US obesity prevalence increased by over a third, with the prevalence of severe
obesity increasing by 96%. Nearly 3 in 4 adults are classified as overweight or obese, and 13% of these
adults have severe obesity. Over this same period, the prevalence of obesity among children and
adolescents increased by nearly 40%, and the prevalence of severe obesity increased by 70%.
Approximately 16% of children and adolescents are overweight and another 20% are obese. These
figures have led policymakers and public health officials to call obesity a national epidemic.
Obesity is expensive in terms of lives lost and cost to the healthcare system. Severe obesity is
estimated to shorten life expectancy by up to 14 years, and the estimated annual medical cost of obesity
is nearly $200 million. Individuals with excess bodyweight are at elevated risk for the leading causes of
preventable, premature death, including heart disease, diabetes, and at least 13 different types of cancer.
Compared to healthy weight children, obese children are more likely to have elevated blood pressure,
display early signs of atherosclerosis, have a four times greater risk of developing type 2 diabetes, are
more likely to develop cancer by age 30, and are more likely to die by age 30.
To help address the obesity epidemic, the CDC’s Division of Nutrition, Physical Activity, and
Obesity awards state and county health departments, land-grant universities, and community-focused
groups funds to support programs promoting physical activity and nutrition across the lifespan. To identify
the effects of federal funds for obesity prevention on weight-related health behaviors, the prevalence of
obesity, and the incidence of obesity-related chronic health conditions, our study will leverage variation
in which counties and states received awards, when they received the awards, how much funding they
received, and the demographic groups targeted by the awards. In doing so, our project will yield important
insights for public health officials looking to understand how to reduce the prevalence of obesity in their
own local settings.

Public health relevance
Project Narrative By 2030 almost half of adults are projected to be obese, with nearly 25% projected to have severe obesity. As relatively little is known about how to reduce the prevalence of obesity, our proposal will provide new evidence on the effects of awards from the CDC’s Division of Nutrition, Physical Activity, and Obesity to state and local health departments, land-grant universities, and community-focused organizations, aimed at promoting healthy eating and physical activity. To study the effects of federal funding for obesity prevention on weight-related health behaviors, the prevalence of obesity, and the incidence of obesity-related chronic conditions, we will leverage variation in which states and counties received these awards, when they received the awards, the size of the awards, and the demographic groups targeted by the awards.